SUDDEN INFANT DEATH SYNDROME (SIDS) RISK REDUCTION IN NORTHERN TIER AMERICAN AND ALASKAN COMMUNITIES SAFE SLEEP OUTREACH PROJECT

SUDDEN INFANT DEATH SYNDROME (SIDS) RISK REDUCTION IN NORTHERN TIER AMERICAN AND ALASKAN COMMUNITIES SAFE SLEEP OUTREACH PROJECT